Extending the scope of PLX-R18 for H-ARS: efficacy in special populations and DEARE

ABSTRACT
The growing threat of terrorist events involving radiation, as well as the potential for radiation accidents,
underscores the need for effective medical countermeasures (MCM) against radiation. The blood-forming system
is the most sensitive tissue to radiation, resulting in the hematopoietic acute radiation syndrome (H-ARS) after
high dose radiation exposures and death from infection and/or bleeding if untreated. Survivors of H-ARS suffer
later in life by the delayed effects of acute radiation exposure (DEARE), a number of chronic illnesses affecting
multiple organ systems. To date, Neupogen (granulocyte-colony stimulating factor, G-CSF) and Neulasta
(pegylated-G-CSF) are the only MCM approved by the FDA for treatment of H-ARS, and will be given as first-
line treatments for individuals exposed to high dose radiation. Neither of these MCM, nor any other effective H-
ARS MCM to our knowledge, have shown efficacy for DEARE, although cell-based MCM have not yet been
evaluated. PLX-R18 cells are a human placental-derived cell product that have been shown to significantly
increase survival in H-ARS animal models, and is under development for FDA licensure as a MCM against
radiation. Given the efficacy of PLX-R18 to reduce kidney and heart injury in re-perfusion ischemia models, there
is rationale that these cells may have efficacy in DEARE also. Most studies testing MCM for H-ARS have used
young adult animal models but it is becoming increasingly clear that responses to radiation and MCM are age-
dependent, and that MCM that are effective in adults may not be effective in children or the elderly. Thus, MCM
for H-ARS should also be tested in pediatric and geriatric animal models. Most animal models are developed in
inbred mice, which are similar to “identical twins” and thus poor models of the human population. Jackson
Diversity Outbred (JDO) mice are the most genetically diverse mice available and a more relevant model of
humans. The goal of this project is to extend the PLX-R18 H-ARS studies to include examination of survival
efficacy in special populations (pediatric an geriatric) and outbred mice, and the ability of PLX-R18 to alleviate
DEARE in survivors. We will also examine potential interactions with G-CSF. We hypothesize that PLX-R18
fulfills all the requirements of an ideal MCM and will demonstrate significant survival efficacy in special
populations and outbred mice, alleviate some aspects of DEARE in H-ARS survivors, and will not interact
negatively with G-CSF when co-administered. The following specific aims will be pursued: 1) evaluate the
survival efficacy of PLX-R18 in pediatric and geriatric inbred mouse models and in the JDO mice, 2) explore the
interaction of PLX-R18 cells with G-CSF in young adult, pediatric, geriatric, and JDO mice and determine
mechanisms of survival efficacy, and 3) investigate the ability of PLX-R18 cells to reduce DEARE in
hematopoietic, renal, and cardiovascular systems. Successful completion of this project will extend the scope of
PLX-R18 to special populations and in DEARE, and will provide treatment options for special populations
exposed to malicious or therapeutic radiation.

Public health relevance
NARRATIVE - “Extending the scope of PLX-R18 for H-ARS: efficacy in special populations and DEARE.” The overall aim of this proposal is to document the survival efficacy of PLX-R18 cells in special populations, (pediatric and geriatric mice) and outbred mice in models of the hematopoietic acute radiation syndrome (H- ARS), and to determine any potential interactions with the approved medical countermeasure G-CSF. We will also investigate the ability of PLX-R18 cells to reduce the delayed effects of acute radiation exposure (DEARE) in hematopoietic, renal, and cardiovascular systems of mice that were treated with PLX-R18 for H-ARS.